Renewal of Delaware Center for Neuroscience Research

Summary
The Delaware Center for Neuroscience Research, established in 2012 with a phase I COBRE
award, is a collaboration between Delaware State University (DSU) and the University of Delaware (UD)
that uniquely brings together faculty and research resources from two very different institutions: a
minority-serving, undergraduate university with an emerging strength in neuroscience research (DSU),
and the state's flagship research university (UD). Phase I of the COBRE project was focused on
supporting the research and professional development of a group of early stage investigators that included
Project Leads, Pilot Grant PIs, and new faculty who were hired at DSU with COBRE support, and
helping the investigators achieve grant success and scientific maturity. The program has been very
successful with over 70 publications by COBRE-supported researchers, three Project Leads “graduated”
into R01 support, a pilot investigator graduated to an NSF CAREER award, and two of the new faculty
recruited to DSU with COBRE support winning K01 awards. Our phase II project will strengthen both
our Center and neuroscience research in Delaware by catalyzing institutional investment in research
infrastructure and continuing to grow the number of R01-competitive neuroscience researchers.
Supporting our COBRE effort as we move to Phase II, UD has made a significant investment in the
research infrastructure for neuroscience with the purchase of a 3T MRI scanner with the capability to map
human brain activity, and the establishment of the Center for Biomedical and Brain Imaging. Our phase
COBRE II award will catalyze additional investment in the purchase of a 7T, small bore magnet to
expand the capabilities of the CBBI to include magnetic resonance imaging of rodent models.
The overarching scientific goal of our Neuroscience Center is to bring together and support
neuroscientists working at multiple scales, from human subjects to rodent and invertebrate models to
improve our understanding of the dynamic function of the brain. During Phase II we will pursue three
specific aims for our Center: 1) strengthening the research infrastructure and capacity in Delaware by
fully developing the Center for Biomedical and Brain Imaging to include instrumentation and expertise
for small animal MRI; 2) to further develop the interdisciplinary, inter-institutional Delaware Center for
Neuroscience Research as a supportive scientific community focused on investigating dynamic structure-
function relationships in the brain; and 3) to involve a new group of investigators in the Center's
integrated mentoring and professional development program that helps junior faculty become
independent, externally-funded researchers. Continuing this COBRE program will have two significant
long-term benefits. First, we will continue to advance to our Delaware Center of Neuroscience Research
to be a self-sustaining, and competitive research center that will advance our understanding of the brain
and increase the amount of multidisciplinary biomedical and behavioral research carried out in Delaware.
Second, the Center will support a group of early-stage faculty to become R01-funded investigators and
advance to senior levels both academically and scientifically.

Public health relevance
Continued support for Our COBRE-supported Delaware Center for Neuroscience Research will allow the Center to continue to expand and strengthen Delaware's infrastructure and human resources to support research aimed at determining how thoughts, memories, feelings and actions emerge from dynamic activities in the brain and how brain functions change over time. Our Neuroscience Center serves as an umbrella organization that leverages the neuroscience community and research infrastructure that has been formed with NIH and institutional investments to advance the research capacity of our state, propel scientific advancement in understanding the brain and nervous system, provide an innovative, interdisciplinary program of doctoral-level research training and professional development, and engage the future generation in STEM through undergraduate research training and K-12 outreach. The Center will bring together resources, expertise and experiences to develop a group of promising early stage faculty into scientifically mature, externally-supported researchers. The Center will also support full development of a unique research resource, the Center for Biomedical and Brain Imaging that will bring together biologists, psychologists, biomedical engineers and others studying human brain imaging with molecular, cellular and behavioral neuroscientists using animal models to allow multi-scale investigations of structure- function relationships in the brain.